Research Education Core

The Research Education Core’s (REC) training model is anchored in contemporary adult learning
theory and calls upon our deep experience cultivating scholars who have competing administrative,
clinical, and production demands. The leaders of REC have reϐined an approach that anchors each
embedded scholar with a dedicated mentor, who supports them in the conduct of a carefully
curated embedded research project that is aligned with the needs of the entity that supports their
engagement with PERLHS. The scholar will learn core fundamental skills and develop
individualized specialized expertise in an area most central to the scholar’s work. By enrolling
embedded scholars annually as a cohort of learners, the program ensures engagement and
collegiality. By relying heavily on a ϐlipped-classroom model, the REC insures that the program
works for embedded researchers who have competing demands. By having mentors that provide
intensive biweekly meetings, the REC insures individualization and progress. LHS-based research
requires that multiple disciplines work together to produce the science and to translate its results;
any one individual will not be expert in all LHS competencies. However, the REC will assure that
each learner gains broad foundational knowledge and has the skills to assemble and lead teams of
experts with skills to realize the goals of the LHS. The specialized expertise that each scholar will
pursue will be towards gaining specialty knowledge and skills vital to one portion of the LHS’s
functioning. To achieve these educational goals, after conducting a needs assessment, the directors
of the REC will reϐine the curriculum and processes of PERLHS Academy to include: core and
specialized didactic material, as well as core and specialized experiential learning sessions,
appropriate for the identiϐied needs of the learners. The directors will assure that the PERLHS
scholars create and complete individual learning plans that will allow attainment of the higher-level
CER/PCOR competencies needed for their embedded projects. The directors will closely supervise
the mentoring of the diverse PERLHS scholars as they complete projects in the LHSs in which they
are embedded. We expect that this approach will be particularly impactful given the inclusion of
embedded learners from across the individual- to population-focused entities in which the LHS
concept is essential; the use of tailored lectures and discussions, both asynchronously and in-
person; our tailored experiential learning; and the commitment of diverse mentors from across the
LHS cycle who will work closely with the scholars as they complete their embedded projects.